Neurobiology of aging in the bat

ABSTRACT
Calcium dysregulation is a critical contributor to neuronal loss in normal aging and neurodegenerative
diseases. An important cause of calcium dysregulation is the loss of calcium binding proteins such as
parvalbumin, calbindin and calretinin. They serve as calcium buffers/sensors in many cells, especially
inhibitory neurons. An important consequence of calcium dysregulation is calpain activation, which is
postulated to cause brain aging and neurodegeneration. We hypothesize that there is (1) a progressive loss
of inhibitory neurons expressing calcium binding proteins, (2) disinhibition in affected brain regions, and (3)
increased calpain activation due to disinhibition as a function of age. Calpain activity will thus drive
neurodegeneration due to aging. To address this, we propose to use an attractive, but understudied model
of aging: Carollia perspicillata, the short-tailed fruit bat. Carollia has a lifespan >10 years and their
neuroanatomy is closer to that of primates than rodents are. We will determine age-dependent changes in
claustrum, hippocampal formation, and basal ganglia. Specifically, we will evaluate the expression of
calcium binding proteins (parvalbumin, calbindin, calretinin) and the expression and activity of calpains 1
and 2 and relate these changes to inhibitory control of neuronal networks. The data obtained from this pilot
grant will serve as a foundation for detailed mechanistic studies of neurodegeneration caused by aging and
disease.

Public health relevance
NARRATIVE Dysregulation of the critical intracellular calcium balance is an established contributor to neurodegeneration in aging and disease. Disruption of buffering by calcium binding proteins can lead to calpain activation and neuronal death. In this pilot project, we will use the long-lived fruit bat as a model system. We intend to define the age-specific changes in calcium binding protein expression, changes in calpain expression and activity, and the functional consequences of these changes in claustrum, hippocampal formation, and basal ganglia. This pilot study will be a foundation for more detailed studies of targeted therapeutics for neurodegeneration.